Cellular reprogramming of cochlear glial cells to regenerate auditory neurons

PROJECT ABSTRACT
Sensorineural hearing loss is a major public health issue; by 2050, over 900 million people will have some form
of auditory impairment. The spiral ganglion nerve (SGN) plays a crucial role in hearing by transmitting acoustic
signals from the inner ear to the brain. Because the auditory nerve lacks intrinsic regenerative capacity,
damage to the nerve leads to permanent deafness. Cochlear implants are ineffective when the SGN is
damaged or lost, as observed in auditory neuropathy (AN) cases. Therefore, there is a critical need to develop
novel treatments for AN, and regenerative medicine holds enormous potential to restore SGN and treat this
condition. The spiral ganglion glial cells support, nourish, and protect the SGN and are critical for auditory
nerve function, development, and homeostasis. Direct neuronal reprogramming converts somatic cells to
induced neurons by overexpression of neuronal transcription factors (NTFs), bypassing the pluripotent state.
The spiral ganglion glial cells are considered a promising source for cellular reprogramming in the inner ear
because of their plasticity, proliferative capacity, survival post-nerve damage, and proximity to the nerve.
Recent work has shown that neonatal spiral ganglion glial cells can be converted into SGNs by overexpression
of NTFs in vitro and in vivo. However, despite administering multiple NTFs, reprogramming spiral ganglion glial
cells remains inefficient. Recent cellular reprogramming strategies incorporate neuroregulatory microRNAs
(miRNAs) to enhance the conversion of fibroblasts into induced neurons in combination with NTFs. The role of
these miRNAs in regulating SGN fate is unknown. Our primary goal in this grant proposal is to convert spiral
ganglion glial cells into SGNs via gene therapy and to advance cellular reprogramming in the inner ear. We
identify three knowledge gaps in advancing cellular reprogramming in the inner ear: 1) We know very little of
the glial cell response after SGN damage, 2) driving exogenous transgenes specifically into glial cells is
challenging, and 3) reprogramming of spiral ganglion glial cells into neurons is very inefficient, and it is not
clear if this generates the correct neuronal subtypes. We hypothesize that spiral ganglion glial cells can be
converted to SGNs in normal and deafened mice with a combination of NTFs and miRNA delivered to the glial
cells via an AAV vector. The aims of this project are (1) the characterization of age-related glial cell response
to acute SGN apoptosis by creating a neonatal mouse model of AN, (2) to optimize exogenous transgene
delivery into cochlear glial cells in neonatal mice, and (3) explore direct reprogramming of normal or damaged
glial cells in vitro. The expected results of this study will be (1) an improved understanding of age-related
changes in reactive gliosis in mice in response to SGN death, (2) improved targeting of cochlear glial cells with
a combination of glial cell-specific AAV serotypes and promoters, and (3) providing experimental evidence of
the role of NTFs and miRNA in inducing SGNs from normal and post-damaged glial cells.

Public health relevance
PROJECT NARRATIVE Damage to the spiral ganglion nerve leads to permanent deafness, and a cochlear implant is the most effective treatment for severe-profound deafness. However, cochlear implants are ineffective with neuronal degeneration, and regenerative medicine, such as direct neuronal reprogramming to replenish the damaged spiral ganglion neurons, holds enormous potential to cure deafness and improve cochlear implant outcomes. This grant explores approaches to advance cellular reprogramming of cochlear glial cells into induced spiral ganglion neurons using a new mouse model with selective ablation of spiral ganglion neurons, optimizing gene delivery into cochlear glial cells, and enhancing reprogramming efficiency by combining micro RNAs with neuronal transcription factors.